Administrative Core

The Administrative Core (Core A) will provide the organizational management to assure that the program project meets its objectives effectively. The specific aims are: Aim 1. To establish an organizational structure that assures effective scientific progress. A major goal of the Administrative Core is to establish an organizational structure that allows effective scientific progress. A system will be established to promote synergy amongst investigators and that resources are appropriately allocated. In addition, a mechanism will be established to allow ample communication amongst the scientific team members and with External Scientific Advisory Panel and NIH program staff. Aim 2. To establish and maintain an infrastructure to support the fiscal monitoring and reporting requirements of the project. A critical role of the Administrative Core will be to provide strong financial and administrative management of the program. This goal will be accomplished through the efforts of an outstanding administrative team comprised of a Program Manager, a Financial Administrator, and an Administrative Assistant. Aim 3. To establish and maintain a system to promote coordination of communication, scientific interchange and collaboration. A major goal of the Administrative Core is to enhance scientific interchange and collaboration among investigators with the goal of rapidly developing new vaccine delivery platforms that meet scientific objectives of novelty and the practical objectives of efficacy, and evaluating B cell immune responses in detail against vaccine candidates. To ensure sharing of resources and research output, the Core will be responsible for creating and maintaining a consortium website as well as scheduling regular meetings of the participants.

Public health relevance
The major goal of this proposal is to develop novel vaccine delivery platforms to enhance B cell immune responses against HIV-1 with a long-term goal of developing a protective AIDS vaccine. This Adiministrative Core will establish an organizational structure to manage the Program and to facilitate scientific collaboration among investigators from multiple institutions.